Cognitive and Contextual Factors in Suicide Ideation Persistence in Adolescents

Cognitive and Contextual Factors in Suicide Ideation Persistence in Adolescents. Deaths from suicide continue
to be a major public health concern, particularly among youth for whom suicide ranks as the second leading
cause of death. Recent suicide ideation is reported by almost 20% of high school students, and the majority of
those report persistent ideation of more than one year. If the factors that associate with persistent and remitting
suicide ideation can be identified, then resources can be directed to those most at risk, with a likely impact on
rates of suicide. Depression, hopelessness, and psychiatric diagnoses have been studied as risk factors for
over 50 years, yet they are neither sufficient, nor effective, for understanding suicide risk. It is important to
evaluate cognitive and contextual factors for suicide ideation, which are understudied, particularly for rural
youth. Cognitive factors that may relate to suicide ideation are defeat, entrapment, grit, and self-efficacy.
Contextual factors with potential to make an impact on suicide ideation are socio-economic status, access to
lethal means, social support, food and housing security, and access to health care. The parent grant
(2R15MH113045-02) aims to fill these knowledge gaps through a 12-month longitudinal study of 225 non-
clinical, rural adolescents between the ages of 14 and 18 who report a history of suicide ideation. The parent
grant proposes that cognitive and contextual factors will differentiate adolescents with and without suicide
ideation history in the baseline sample. It is further expected that the cognitive factors defeat and entrapment
will associate with persisting suicide ideation, and self-efficacy and grit will associate with remitting suicide
ideation at follow-ups. Lastly, it is expected that contextual factors will associate with persisting (low SES and
access to lethal means) vs. remitting (social support, food and housing security, access to health care) suicide
ideation at follow-ups. This diversity supplement will augment the parent grant by supporting a second-year
master’s student trainee who will examine how sexual and gender minority (SGM) status associates with these
factors and persistent suicide ideation. Adolescents in 9th-11th grades will be recruited to complete a research
protocol of self-report and behavioral measures at their home schools at baseline (n=700); adolescents with
suicide ideation history (est. n=225) will be recruited into follow-up assessments at 6- and 12-months post
baseline. Teacher reports for the 225 adolescents with suicide ideation history will also be collected. ANOVA
will be used to determine how cognitive and contextual factors and suicide ideation history differ for SGM vs.
cisgender, heterosexual students. To test hypotheses about factors associating with suicide ideation
persistence and remittance and if these associations depend on SGM status, moderation analyses will be
used. SGM status will be tested as a moderator in the relationships between risk factors and suicide ideation
persistence. The supplement will also provide research and career mentoring for the trainee, to assist in
advancing their goals of attending a Clinical Psychology PhD program and establishing a research career.

Public health relevance
Adolescents with persistent suicidal thoughts are at greater risk for future suicide attempts. Students identifying as gender and sexual minorities (SGM) are at even greater risk for suicide. Identifying factors that relate to diminishing suicide ideation will aid in the development of prevention and early intervention programs for SGM youth.